Cancer Center Support Grant

Salk Cancer Center – Overall Project Summary / Abstract
The Salk Institute Cancer Center is a premier cancer research center that uses innovative and collaborative
approaches to tackle some of the most pressing challenges facing cancer biologists today. Researchers in the
Salk Cancer Center are employing cutting edge genomic, epigenomic, transcriptome, and metabolomic
approaches to molecularly characterize cancer. The goals of this research are to develop new diagnostic tools
and to also define cancer subtypes so that clinicians will be able to select the most effective therapeutic
approaches, while also identifying new molecular targets. Salk Cancer Center researchers are at the forefront
of developing and applying these approaches; discoveries like reprogramming tumor metabolism and tumor
microenvironment have the power to revolutionize diagnostics and are already demonstrating tremendous
potential in the clinic.
The Salk Cancer Center is building upon its outstanding foundation in basic discovery science to identify and
develop new therapeutic targets for multiple tumor types. Cancer Center researchers have discovered new
cancer genes, identified potential therapeutic targets, and defined new drug resistance mechanisms. During
this past funding period, multiple basic discoveries from a handful of labs at the Salk Cancer Center have led to
early phase clinical trials, greatly expanding translational efforts at Salk. Over the next five years, as part of the
Conquering Cancer Initiative, the Salk Cancer Center will bring more of its basic research discoveries to
preclinical and clinical settings.
Funding from the National Cancer Institute provides the Salk Cancer Center with the organizational and
financial support needed to make a significant impact on cancer diagnosis and treatment. The two reorganized
research programs (Genetic, Epigenetic, and Immune Circuits in Cancer; Animal Models of Cancer and
Therapeutics) provide opportunities for members to come together, maximizing collaboration and
communication.
The seven Shared Resources provide access to technologies, services, and expertise to enhance productivity
and promote multidisciplinary interactions. Essential Developmental Funds enable the Center to remain at the
forefront of cancer research. Together, these elements of the Salk Cancer Center create an environment that
supports the level of scientific discovery required to make real progress in improving cancer diagnosis and
treatment.

Public health relevance
Salk Cancer Center – Overall Project Narrative Despite decades of research, more than half a million people die of cancer each year in the US. The research mission of the Salk Cancer Center is to understand the fundamental aspects of biology related to cancer. With world-renowned scientists and state-of-the-art facilities, the Salk Cancer Center is continually making basic research discoveries and translating these major new insights in cancer biology into new clinical opportunities for diagnostics and therapeutic treatment.